The Participant Center: Empowering All of Us Research Program participation across the United States

A. Abstract
The Participant Center (TPC) will 1) maintain capabilities that enable full All of Us Research
Program (All of Us) participation across the United States (US) and 2) lead innovation in the
participant experience in support of program goals. TPC is an alliance of more than 25 partners,
led by Scripps Research.
TPC makes it possible for interested individuals anywhere in the U.S. to join and remain
engaged in All of Us. TPC will reach individuals where they are through approaches ranging
from light touch digital outreach to high touch, in-person one-on-one support. TPC strategies and
tactics aim to support the recruitment of over 200,000 new baseline participants, while upholding
the program’s goal to reflect the rich diversity of the US by including 50% participants who have
been historically underrepresented in biomedical research (UBR) based on their race and/or
ethnicity, and 80% participants who are UBR based on any program-defined category. We aim to
maintain at least 75% active retention, in line with TPC’s current active retention rate of 86%.
Drawing on our experience in All of Us since 2016, including the recruitment of over 97,000
participants and support of biospecimen collection from over 44,000 participants, we will
improve on the processes and relationships we have built to further the program’s mission to
enable individualized health care.
TPC will utilize All of Us Participant Labs (APL) to implement participant-facing innovation that
accelerate progress toward program goals. Employing streamlined processes and dedicated
innovation infrastructure to carry out a portfolio of high risk/high reward initiatives, we will
manage an innovation pipeline while minimizing program risk. Data-driven decisions will be
made in each step of the process, from literature reviews informing idea development to impact
evaluations that measure participant responses. Opportunity cost will be carefully considered,
and projects will be abandoned if they are a suboptimal use of resources. Initiative ideas will be
solicited from all consortium stakeholders and selected through a process that includes alignment
with NIH goals and roadmaps and the APL focus areas of enrollment, engagement, retention,
biospecimen collection, and research data collection. Beginning with APL initiatives, we aim to
combine novel data collection with multi-modal artificial intelligence (AI) to return personalized
information and improve participant health.